Development of a lacO/lacI based flourescence reporter-operator system to study chromosome dynamics in mice

SUMMARY
Meiotic chromosomes undergo a range of motions promoting highly regulated chromosome interactions. These
interactions culminate in pairwise associations of maternal and paternal homologous chromosomes, which are
later stabilized via the proteinaceous structure called synaptonemal complex (SC) that forms between the
homologous chromosomes (synapsis). Chromosome pairing and SC formation are influenced by rapid prophase
movements (RPMs). Mutations that affect chromosome motions or SC dynamics can lead to costly phenotypes
ranging from problems in reproductive biology and fertility to severe aneuploid-based birth defects. Fundamental
questions regarding the processes underlying RPMs, and how RPMs lead to stably homologous chromosome
pairing are poorly understood. Equally important, double-strand breaks are essential for meiotic recombination
to occur allowing homologous interactions. However, how timing and genome distribution of double strand are
controlled is poorly understood. A prominent candidate for this control is the recently identified SPO11 partner,
the ANKRD31 protein, whose precise mechanism of action and targets in germ cells are unknown. Molecular
studies in mouse have been traditionally limited by the lack of genome engineering tools. This proposal builds
on the development of an innovative approach that directs proteins to chromosomal loci in mouse meiocytes in
vivo by utilizing a fluorescence reporter-operator system (FROS) using lacO-lacR technology. Our preliminary
data shows that this system has the potential to answer questions that have previously been intractable for
mouse meiosis relevant to differentiation and maturation of male germ cells. The planned experiments will
answer two specific questions: 1) how do chromosome motions promote stable homolog pairing and 2) what is
the action mechanism of ANKRD31 in mediating proper timing and location of meiotic double strand breaks?
The first Aim will assess the mechanism and regulation of RPMs on homologous chromosome pairing. We will
use lacO/lacR-GFP to visualize and quantify chromosome motions using 3D time-lapse movies in mammalian
live germ cells. We will test how previously unrecognized chromosome characteristics (e.g. chromosome location
within the nucleus and chromosomal level of expression) that modulate RPMs. Additionally, our newly developed
long-term seminiferous tubule culture system will allow us to directly test two competing models explaining how
homologous chromosomes interact and pair. This aim will lend new insights into the dynamic forces that govern
homolog pairing in space and time. Aim 2 will determine the requirements of the ANKRD31 protein in meiotic
double strand formation. To this end we plan to generate transgenic mice carrying lacO repeats and ANKRD31-
GFP-lacR. Targeting ANKRD31 fusion to specific genomic loci will allow direct evaluation of ANKRD31 effect on
local accumulation of SPO11 auxiliary proteins (REC114, MEI4, and IHO1), downstream recombination hotspot
intermediates, and frequency of double strand break formation.

Public health relevance
Narrative Errors in the process of distributing chromosomes to the gametes, are the major cause of spontaneous abortions and birth defects and are an important contributor to infertility. This project uses a novel technology based on lacO/lacR (Operator/Repressor) and combines genetic and cellular approaches to unravel the mechanisms by which homologous chromosome find each other and establish permanent connections through the formation of the synaptonemal complex, all of which is of paramount importance in preventing the chromosome segregation errors that lead to birth defects.